Investigating TCF4 and Synaptic Dysfunction in Pitt-Hopkins Syndrome

PROJECT SUMMARY
Autism spectrum disorders (ASDs) present a complex array of neurodevelopmental challenges, affecting
approximately 1 in 100 individuals globally. Despite substantial efforts to understand the genetic underpinnings
of ASD, therapeutic treatments remain elusive. Transcription factor 4 (TCF4) loss-of-function (LOF) mutations
are implicated in Pitt-Hopkins syndrome (PTHS), a syndromic form of ASD. While PTHS pathophysiology has
been extensively studied in murine models, understanding TCF4 function within a human context is imperative.
This proposal aims to utilize patient-derived induced pluripotent cells (hiPSCs) to model synaptic transmission,
focusing on presynaptic regulatory roles of TCF4 and the therapeutic potential of RIMBP2 re-expression.
Our recently published data indicate significant deficits in spontaneous excitatory postsynaptic currents
(sEPSCs) and network activity in PTHS hiPSC-derived neurons, potentially stemming from presynaptic
abnormalities. From our differential expression gene analysis, RIMBP2, a presynaptic organizer, emerged as
the most significantly downregulated gene, with its re-expression rescuing deficits in network synchronicity and
sEPSC frequency. In this study, I will explore the impact of TCF4 LOF on presynaptic release, subcellular
protein localization, and ultrastructure, along with mechanism by which RIMBP2 rescues deficits. In aim
1, I will employ live-cell imaging with the glutamate sensor iGluSnFR3 to quantify presynaptic release deficits
and changes in evoked neurotransmitter release, release probability, and coupling distance between release
ready vesicles and calcium channels. Additionally, with time-resolved electron microscopy, I will examine deficits
in synaptic ultrastructure. In aim 2, I will characterize deficits involving calcium channel conductance, expression,
and localization. First, I will measure presynaptic calcium influx with the calcium sensor SynG-Camp6f. Then,
using quantitative microscopy, I will assess the expression and localization of calcium channels along with
related proteins in the active zone. Finally, I will employ live-gold-labeling electron microscopy to measure the
coupling distance between calcium channels and docked vesicles at the nanometer scale.
The significance of this research lies in elucidating the synaptic deficits associated with TCF4 LOF, providing a
foundation for targeted therapeutics. The anticipated results could identify candidate genes and inform novel
approaches to restore presynaptic release deficits linked to TCF4 dysfunction in PTHS. The study's innovative
methodology, incorporating advanced imaging techniques and human-derived models, contributes a unique
perspective to understanding the synaptic architecture of neurons affected by TCF4 mutations. With the support
of my proposed mentorship team and the outstanding training environment, the research and training activities
proposed here will ideally position me for a future career in academic neuroscience research.

Public health relevance
Project Narrative Investigating the synaptic deficits associated with TCF4 loss-of-function (LOF) in Pitt-Hopkins Syndrome (PTHS) holds significant public health relevance as autism spectrum disorders (ASDs) affect approximately 1 in 100 individuals globally. Despite the prevalence of ASDs, there is a lack of targeted therapeutic interventions, particularly addressing presynaptic contributions to the pathology. Understanding the molecular mechanisms underlying TCF4 dysfunction and the potential therapeutic impact of RIMBP2 re-expression could provide insights into novel treatment approaches for ASDs, addressing a critical gap in current therapeutic options for this complex neurodevelopmental condition.